Thermodynamic and Functional Analysis of Consensus and Covariance in Proteins, and Bivalent Notch Complexes

SUMMARY
It is an exciting time for research in molecular biosciences. The scientiﬁc community has
amassed a huge database of protein sequences and structures, and techniques to analyze their
structures and stabilities have undergone steady improvement. These advances have helped fuel a
revolution in computational methods, based on artiﬁcial intelligence (AI), to interpret protein
sequence information and to predict new structures and sequences. Together, these advances will
help treat disease and provide a deep understanding of how proteins work.
Research in our lab focuses on protein structure, stability, assembly, and function. We have
leveraged large sequence databases to discover ways to stabilize proteins, and to understand the
sequence features that contribute to protein function. We have found that “consensus proteins”—
where sequence is determined simply selecting the most frequent residue at each position—are
extraordinarily stable. These proteins provide a route to design active and resilient proteins that can
be used in therapeutic and industrial applications. In the next ﬁve years, we will expand our design
strategy to include sequence correlations between groups of residues. These correlations have
been important for the success of AI in predicting protein structures, and have been suggested to
enhance protein stability, ﬁtness, and activity. Our preliminary ﬁndings provide a different
interpretation, and suggest a new and unrecognized way to stabilize proteins beyond consensus
while maintaining biological activity. We will use a set of proteins developed in our lab to test and
extend these ﬁndings. We will also use this set of proteins to test how well AI-based methods
generate high-stability proteins, which will help to evaluate and improve current AI tools.
In parallel, our lab studies the molecular fundamentals of a speciﬁc signaling system, the Notch
signaling pathway, in cell differentiation and disease. We are focusing on a multiprotein transcription
complex central to Notch activation, and have developed new methods to measure the overall
energy of assembly and dissect the contributions of different parts of the complex. Beyond providing
new methods for analyzing molecular complexes, we will learn how disordered chains can couple
together distinct binding motifs to enhance binding and switch the complex between different states
of assembly. Our studies will also reveal how different but related Notch molecules lead to different
biological outcomes, and how disease mutations disrupt different steps in complex assembly.

Public health relevance
NARRATIVE The proposed research will improve our understanding of the sequence features that determine protein stability and function. This information will be used to improve methods for protein design, which will help to generate new protein therapeutics and diagnostic tools. The research will also reveal the mechanisms that underlie Notch signaling in humans, and will provide an understanding of what goes wrong in Notch-related diseases.